TRAINING GRANT IN ACADEMIC NUTRITION

Project Summary/Abstract
This renewal application for the Training Grant in Academic Nutrition brings together the faculty
and physical resources of the Harvard T.H. Chan School of Public Health and Harvard Medical
School, fosters close interactions between trainees and faculty, and includes 31 faculty
preceptors in several areas of nutrition. The Principal Investigators, Drs. Frank Hu and
Christopher Duggan, have proposed a strong and vigorous pre- and postdoctoral training
program. The Training Program has successfully recruited an outstanding cadre of applicants
who demonstrate intellectual promise and dedicated commitment to nutritional science
research. Our program provides training in four key areas: Nutritional Biochemistry (including
genomics/metabolomics/microbiome), Human/Clinical Nutrition, Nutritional Epidemiology, and
Public Health Nutrition. Our overall goal is to incorporate concepts, approaches, and scientific
tools from both basic and applied science so that trainees are able to transcend conventional
specialty boundaries. This Training Program is designed both for individuals who have recently
completed their master's or undergraduate degree and are entering a formal doctoral program,
and for physicians and graduates of other doctoral programs who will enter an intensive
research training program with options to obtain formal degrees. In this renewal application, we
propose to work closely with the MD/PhD program to identify and encourage Harvard medical
students to apply to our training program as part of their joint degree requirements. Regardless
of track, all degree candidates must successfully complete didactic coursework involving both
basic biochemical and molecular concepts and advanced training in quantitative sciences,
including epidemiology and biostatistics. All trainees participate in demanding hands-on
preceptor-guided nutritional science research guided by well-funded nutrition scientists.
Trainees of this program, of whom 33% are under-represented minorities, have established a
strong record of publication and success in obtaining grants and faculty positions. Over the next
five years, we propose that this program support 4 predoctoral and 4 postdoctoral trainees
annually in the academic environment of HSPH and HMS.

Public health relevance
Project Narrative We propose to continue a training program that will prepare outstanding individuals for a research career in nutritional sciences. This program brings together the faculty and physical resources of Harvard TH Chan School of Public Health and Harvard Medical School to provide multidisciplinary didactic and research experiences that transcend traditional specialty boundaries. Training positions are requested for individuals pursuing doctoral degrees in nutrition and for persons who have recently graduated and are seeking postdoctoral training.